Administrative Core

PROJECT SUMMARY
ADMINISTRATION
The goal of Administration is to support the Director’s vision and strategic direction through support and infrastructure that foster innovation, drive collaboration and maximize the quality of the science of the 183 Members that comprise the five research Programs. This includes developing and operationalizing the Research Strategic Plan (RSP); fostering team science through developmental funds, planning and evaluation, and Program activities; delivering communications to all research areas; enhancing innovation through new processes and infrastructure; and providing overall management functions. During the award period, Administration was expanded with four new offices: Community Outreach & Engagement (COE); Planning & Business Operations; Research Education & Training (RET); and the Office of Scientific Development (OSD), to enhance activities in collaboration with area specific Associate Center Directors (ACDs). Administration demonstrates impact through the following Specific Aims:
Aim 1: To manage strategic planning and evaluation activities including the RSP. Administration provides ongoing support of all key planning and evaluation committees and subcommittees, including support of the Research Executive Committee (REX) and the Scientific Leadership Committee (SLC).
Aim 2: To foster Member and team science through developmental funds, activities, and communication. The staff manages more than $2 million in annual developmental awards and oversees business operations for 12 active and 2 development Shared Resources, including chargebacks, performance review, and user satisfaction. The staff arranges and documents approximately 1,300 Center meetings and retreats annually.
Aim 3: To provide overall Center management functions. Administration manages the $170 million annual budget, including philanthropic funds; implements policy for 404,000-ft2 of dedicated research space; conducts the quarterly membership review and monitoring process; leads research administration information technology, and prepares all CCSG documents and reporting.
Aim 4: To enhance innovation through new processes and infrastructure. During the award period, Moffitt supported development of a new faculty model; implemented restructuring of 6 existing Shared Resources; developed a new Instructor position for select postdoctoral fellows; revised Membership criteria; and embarked on a detailed review of clinical trials revenue cycle and trial activation processes.
Impact: Administration provides support for all Center activities. During the period, this has included completing the previous RSP (2014-2018) and developing the new RSP (2019-2023); facilitating a 15.3% increase in peer-reviewed funding to $36.0M; fostering collaboration as evidenced by 68 active MPI grants and 18.7% Inter-programmatic and 24.2% intra-programmatic collaborative publications (543 in high impact journals); completing 72 recruitments; and in FY20 increasing therapeutic accruals to 1,272 (1,310 accruals including affiliates).